Administrative Core

Administrative Core: Project Summary/Abstract
The Administrative and Enrichment Core oversees the Vanderbilt Diabetes Research Center's (VDRC)
interdisciplinary research base and Research Cores. The VDRC leadership is responsible for determining the
membership of the VDRC, allocating VDRC support of research cores, overseeing the Pilot and Feasibility
Program and VDRC training efforts, and developing long-term VDRC strategy. Vanderbilt continues to make a
sustained and substantial commitment of space and resources to the VDRC, and the Administrative
Component is responsible for integrating this with support provided by the NIH. The VDRC leadership, which
brings considerable research and administrative expertise and perspective, consists of: Director (Alvin
Powers); two Associate Directors (Nancy Cox and Owen McGuinness); and a distinguished Executive
Committee. In these VDRC efforts, the Director and the Administrative Component of the VDRC receive advice
from: 1) an Internal Advisory Committee 2) an External Advisory Committee; 3) the Pilot and Feasibility Review
Committee; and 4) a Research Training Advisory Committee. The VDRC's Enrichment Program oversees and
organizes robust enrichment activities, including a weekly seminar series, annual Diabetes Day, regular
meetings of VDRC's interest groups, and the National DRC Virtual Seminar Series. A major goal is to foster
the training and development of new diabetes investigators. In summary, an experienced and effective VDRC
management team, bolstered by sustained and substantial support from Vanderbilt, is working to ensure that
the VDRC's research base, core facilities, training activities, and enrichment efforts continue to be outstanding
and at the forefront of diabetes research.